Mechanisms of neuronal pathogenicity in SPTBN1 syndrome

PROJECT SUMMARY
βII-spectrin, a key component of the cytoskeleton, forms a submembrane lattice that organizes micron-scale
domains of transmembrane proteins. βII-spectrin also facilitates organelle transport and likely provides structural
support and flexibility to neurons. Loss of neuronal βII-spectrin in mice causes early postnatal lethality and
significant alterations in cortical development and axonal connectivity. Heterozygous variants in SPTBN1, the
gene encoding βII-spectrin, cause an early-onset neurodevelopmental syndrome characterized by speech and
motor delays, comorbid with intellectual disability, autism spectrum disorder, ADHD, epilepsy, dysmorphisms,
and cortical deficits, collectively known as SPTBN1 syndrome. Previous structure-function evaluations of disease
variants in heterologous cells and rescue studies in βII-spectrin null murine cortical neurons indicate that
pathogenic mechanisms involve βII-spectrin instability and aberrant binding to key molecular partners. My
preliminary data shows that missense and nonsense SPTBN1 syndrome variants differentially impact βII-
spectrin protein levels and subcellular localization. These findings imply that different groups of βII-spectrin
variants impart neuronal dysfunction through divergent mechanisms. However, the molecular pathways through
which these variants affect the total βII-spectrin pool and downstream βII-spectrin-dependent processes in
human neurons remain unexplored.
In this study, I will evaluate the premise that nonsense and missense SPTBN1 syndrome variants disrupt βII-
spectrin function in human cortical neurons (hCNs) through molecularly distinct pathological changes in
expression and subcellular distribution. I will first study nonsense SPTBN1 variants in hCNs to determine the
molecular and functional consequences of pathogenic βII-spectrin haploinsufficiency compared to βII-spectrin
heterozygous knockout hCNs (Aim 1). I will also interrogate missense SPTBN1 syndrome variants that distinctly
change βII-spectrin levels and distribution, uncover mechanistic basis for these effects, and explore methods to
ameliorate βII-spectrin misexpression (Aim 2). These experiments will leverage the power of endogenous
expression of disease-linked SPTBN1 variants at heterozygous levels in hCNs to uncover mechanistic insights
into SPTBN1 syndrome pathogenesis. Ultimately, this work will guide the future design of therapeutics for
SPTBN1 syndrome and other spectrinopathies of the nervous system.

Public health relevance
PROJECT NARRATIVE Pathogenic variants in βII-spectrin, encoded by SPTBN1, a cytoskeletal protein expressed throughout all neuronal domains, cause a neurodevelopmental syndrome (SPTBN1 syndrome) characterized by developmental delay and intellectual disability, comorbid with autism spectrum disorder, ADHD, and epilepsy. This project will investigate the molecular mechanisms by which pathogenic nonsense and missense SPTBN1 syndrome variants affect βII-spectrin function in human cortical neurons. These studies will contribute to our understanding of the mechanisms of pathogenicity that lead to SPTBN1 syndrome.